Supplement to AMP-AD Brain Proteomic Network Enhancement, Validation and Translation into CSF Biomarkers

The goal of the parent AMP-AD project is to identify proteomic networks from cortical tissue and identify protein co-expression modules that are strongly associated with diagnosis, cognition and neuropathology. These studies hinge on accurate neuropathologic diagnosis and staging of the brain tissue. These assessments typically involve semi-quantitative evaluation of tissues and there is a need for robust, reliable, and scalable deeper phenotyping to provide a firmer foundation for precision medicine approaches. We have developed the Digital Slide Archive (DSA) platform at Emory, which has been funded through a U24 and U01 grants from the NCI/NIH and has primarily been optimized for Cancer related image analysis workflows. In this project, we propose to deploy and customize a web-based instance of our open source management and visualization platform, the Digital Slide Archive (DSA). Ultimately, we will enable collaborative team science and adapt the existing DSA platform for a neuropathologist’s workflow. This will directly enhance the value of our proteomic work by allowing us to better annotate our brain/proteomic samples. In this proposal, we propose enhancing the user interface of the DSA to better accommodate a neuropathologist’s workflow for reviewing brain tissue, and develop an easily installable Neuropath plugin for the DSA. We will also benchmark and optimize our analysis suite (HistomicsTK) on NP slide sides on local and cloud-based computational resources, and prepare tutorials demonstrating how our tools can be used for ADRD related image analysis tasks. These aims paired with the complementary and synergistic expertise of our informatics, pathology, and engineering will aid in development of robust, scalable, reliable, and sharable platforms to provide a foundation for innovative transformative science addressing a critical unmet need in neurodegenerative disease research.

Public health relevance
Project Narrative The overall goal of the AMP-AD project is to identify protein-markers from brain tissue and the CSF that track with Alzheimer's Diseases and Related Degenerative Disorders. This research is all critically dependent upon an accurate neuropathologic classification of brain tissue. We have developed an open-source image analysis platform (the DSA) that has been extensively used in cancer which we propose to enhance the user interface, improve cloud-readiness, and documentation to support this research and improve diagnosis accuracy.